The Impact of Nurse Practitioner Work Environment and Community Characteristics on Acute Care Utilization by Older Adults with Multiple Chronic Conditions

Multiple chronic conditions (MCCs), defined as two or more chronic conditions in the same person, are more
common and costly that any individual health condition in the United States (US). Yet, people with MCCs often
receive primary care that is condition-centric and fragmented, leading to duplicative tests, adverse drug events,
and conflicting medical advice. Such inadequate primary care leads to frequent emergency department (ED)
visits and hospitalizations for exacerbations of these chronic conditions. Social determinants of health,
including low income and poor primary care availability, further worsen patients’ burden of MCCs. Across the
nation, particularly in communities with poor socioeconomic resources, few physicians enter and stay in
primary care while the large and growing workforce of nurse practitioners (NPs) provide safe, cost-effective
primary care in these underserved areas. However, there is a gap in evidence regarding how primary care
practices can support NPs to meet the complex care needs of people with MCCs. Poor NP care environments,
marked by lack of support for NP practice, collegiality between clinicians, and an organizational understanding
of the NP role, deplete organizations of financial and human resources through burnout and turnover,
challenging NPs’ ability to provide care for people with MCCs. Positive NP care environments are associated
with quality care for chronic disease and may help alleviate the negative impact of poor community
characteristics on patients through optimal teamwork, support, and communication. Yet, to date, no study has
investigated the impact of NP care environment on the relationship between community characteristics and
outcomes for people with MCCs. To fill this critical gap in evidence, this dissertation will leverage an existing
dataset from a study conducted by my mentor (R01MD011514 PI: Poghosyan, 2016-2022) which contains
information on NP care environments across six states merged with 1) Medicare claims (i.e., patient
characteristics, ED visits, and hospitalizations), 2) the Socioeconomic Position Index created from US Census
Bureau data, and 3) Primary Care Service Area files indicating primary care service availability. My aims are
to: Aim 1: Assess NP care environments and community characteristics (i.e., socioeconomic position
and primary care availability) of practices caring for patients ≥65 years with MCCs. Aim 2: Investigate
the relationship between NP care environment, community characteristics, and acute care utilization
(i.e., ED utilization and hospitalizations) among patients ≥65 years with MCCs and determine if care
environment moderates the relationship between community characteristics and acute care utilization.
I will have access to ample research infrastructure at Columbia University, and I am supported by an
exceptional mentorship team with expertise in NP workforce, MCCs, multilevel modelling, and dissemination of
findings. This study will produce evidence to improve health for socially and economically marginalized older
adults living with MCCs, an Agency for Healthcare Research and Quality priority population.

Public health relevance
PROJECT NARRATIVE The burden of multiple chronic conditions (MCCs) is amplified by poor community characteristics like low socioeconomic status and poor access to primary care. This study will be the first to investigate whether the relationship between community characteristics and patient outcomes changes at different levels of nurse practitioner (NP) care environment in primary care practices where older adults with MCCs receive care. Findings from this study will guide the design of interventions to improve primary care for older adults with MCCs in practices that employ NPs.